Translational SPECT/CT Imaging System

Summary
This high-end shared instrument grant proposal is to replace the existing hybrid SPECT/CT scanner (Discovery
NMCT570c, GE Healthcare) that was purchased in 2010 with a shared instrumentation grant (1 S10
RR025555-01) entitled, “Hybrid Volumetric SPECT/CT Imaging System”, with a new SPECT/CT that has 12
cadmium zinc telluride (CZT) detector modules in a unique 360° configuration with adaptable detector position
and angle. This new CZT-based SPECT technology is capable of focused or whole-body imaging and will be
applied for radionuclide targeted molecular imaging in larger animals in evaluation of a wide variety of
diseases. The new CZT detector system will provide improved sensitivity and spatial resolution, bringing the
SPECT technology closer to that of PET. The proposed hybrid scanner will facilitate correction for errors
attributed to attenuation, scatter, partial volume effects, and radiotracer crosstalk during dual isotope
acquisitions facilitating quantitative SPECT radiotracer-based molecular imaging. The high sensitivity of the
technology will also enable ultra-fast dynamic SPECT imaging, which should prove to be extremely valuable
for determining the biokinetics of new targeted radiotracers and allows for the determination of absolute blood
flow through established kinetic modeling approaches. The high sensitivity also allows for shorter scan times
as well as respiratory and cardiac gating which will minimize the possibility of subject and/or cardiac motion
and therefore reduce motion related artifacts. The proposed system will enhance our established translational
facilities for imaging of both small and large animals, human cadavers, and facilitate translational research at
our institution. The CZT-based SPECT/CT imaging system will support the needs of multiple current NIH
funded investigators at Yale University School of Medicine, from the Departments of Internal Medicine,
Radiology & Biomedical Imaging, Surgery, and from the Department of Biomedical Engineering at Yale
University as well as investigators at multiple other academic institutions throughout the US. The user group
works on a variety of projects, which would utilize different features of the proposed equipment. The upgraded
hybrid SPECT/CT imaging system will become an integral part of the Yale Translational Imaging Center (Y-
TRIC), which has co-located large animal holding and surgery facilities with state-of-the-art imaging resources
for translational animal research. This center will nicely complement our current Yale Center for Clinical
Investigation (YCCI), which has been repeatedly funded by an NIH CTSA grant for establishing an integrated
environment for clinical and translational research. Funds will be available through the YCCI to fund pilot
projects from new investigators to assure expanded utilization of the system.

Public health relevance
Project Narrative The proposed replacement hybrid CZT SPECT/CT imaging system will significantly enhance the translational research of multiple NIH funded investigators at Yale University School of Medicine, from the Departments of Internal Medicine, Radiology & Biomedical Imaging, Surgery, and from the Department of Biomedical Engineering at Yale University along with NIH funded investigators at other universities. The upgraded system will also be used for dynamic and multi- isotope imaging and improved image quantification facilitating validation of new targeted molecular imaging agents for evaluation of a wide range of diseases involving heart, lung, liver, and kidneys. The application of these types of cutting-edge imaging technologies will provide for improved and personalized health care in the future.